IGF::OT::IGF Centralized Chemopreventive Agent Repository and Drug Chemistry SupportPeriod of Performance 09/01/2011 - 03/28/2016.

This project is for the production of an HPV-vaccine active against all strains of HPV and therefore eliminating the subsequent formation of cervical cancers due to HPV infection.